Administrative

The Administrative Core (Core A) will integrate all scientific and administrative functions of the University of Utah Molecular MedicineTranslational Research Center in Thrombosis (U2M2-TRCT). The Administrative Core will be the primary means by which the Director and Co-Director will catalyze integrative research within the U2M2-TRCT program. Core A will serve as the major administrative resource to all investigators, providing services and support for research projects 1-4, the other three cores, and the Administrative Coordinating Center. Core A will coordinate and oversee all scientific activities of the U2M2-TRCT. These activities include the investigators committee meeting, investigators research-in-progress series, the program newsletter, the Internal Advisory Board, the External Advisory Board, and all seminar series that are related to the U2M2-TRCT. Embedded within these activities is the training and development of young investigators. The Administrative Core will also provide budgetary management, document processing, and graphics support to U2M2-TRCT investigators. Throughout, the Administrative Core will be sensitive to the investigators needs on a daily basis to ensure the maintenance of a unified, collegial atmosphere.

Public health relevance
RELEVANCE (See instructions): Patients with type 2 diabetes, obesity, or the metabolic syndrome are at increased risk for blood clots ("thrombosis") caused by cells called platelets. Our studies will determine how metabolic factors in the blood and tissues ("the metabolic milieu"), such as high glucose and lipids, make platelets more prone to induce thrombosis, providing new insights into the treatment and management of diabetes and obesity.